Pharmacogenomics of Gastric Function & Weight in Obesity

DESCRIPTION (provided by applicant): Obesity arises from increased appetite or ingestion of food over energy requirement. Previous research has identified that the functions of the human stomach are important determinants of fullness while eating, a factor that influences cessation of food intake. Many candidate genes have been associated with development of either obesity (e.g. fat mass and obesity-associated gene, FTO) or type II diabetes mellitus (DM, e.g. TCF7L2). This research proposal seeks to further examine the association of candidate genes with stomach functions (rate of gastric emptying, gastric volume and maximum tolerated volume as a marker of sensitivity) that are associated with fullness while eating. Some candidate genes influence the effectiveness of obesity treatment. In the prior cycle of DK67071, our research team demonstrated, in a randomized controlled clinical trial, that specific markers of three genes controlling adrenergic and serotonergic function (ADR2A, GNB3 and 5- HTTLPR) are significantly associated with weight loss in response to sibutramine. In this proposal, we seek to expand the markers or genetic variants in these genes (ADR2A, GNB3 and 5-HTTLPR) and to explore effects of other genes that are associated with obesity in epidemiological studies (uncoupling proteins [UCP], and FTO, and type II DM [TCF7L2]) on peripheral determinants of satiation and satiety though validated measurements of gastric emptying of solids and liquids by scintigraphy, gastric volume by SPECT, satiation by nutrient drink test and satiety by standardized buffet meal. Our overall, long term aim is to identify susceptibility genes that influence peripheral gastrointestinal functions, reduce satiation and predispose to obesity and that significantly modify weight response to sibutramine. Identifying those genes will also facilitate selection of people who should benefit from new prevention or treatment for obesity directed at the gastrointestinal functions. Our specific aims are: first, to compare maximum tolerated volume, postprandial satiation, gastric emptying, fasting and postprandial accommodation volume in overweight and obese adults with allelic variants at the FTO, ADRB3, uncoupling protein-2, ADR2A, GNB3 loci to adults with common alleles. A second aim is to compare the same functions in non-diabetics, non-obese and adults with impaired fasting glucose who are carriers of the diabetes-associated TCF7L2 allele vs. those with the diabetes-protective allele. A third aim is to assess the pharmacogenetic modulation of weight loss in response to sibutramine 15 mg per day compared to placebo for 12 weeks in obese and overweight adults with allelic variation in the same candidate genes compared to adults with common or disease-protecting alleles. Apart from the specific information about the pharmacogenetics of sibutramine, this research will identify genetic susceptibility to abnormal stomach function that, in the future, may be treated with pharmacotherapy or devices that change gastric function, increase fullness during meals and induce cessation of feeding. Thus, the approach has potential to prevent obesity in those with genetic susceptibility, and to select patients for peripherally targeted weight loss therapies.

Public health relevance
PUBLIC HEALTH RELEVANCE: Previous research has shown that the functions of the human stomach contribute to feeling full while eating; this feeling is reduced in obese people and it may be influenced by inherited genes. This research project examines which candidate genes influence stomach functions associated with fullness while eating among obese people, and which genes influence weight loss in response to the obesity medication, sibutramine, in order to select the right patients for treatment of obesity with this medication. Project Narrative / Relevance Previous research has shown that the functions of the human stomach contribute to feeling full while eating; this feeing is reduced in obese people and it may be influenced by inherited genes. This research project examines which candidate genes influence stomach functions associated with fullness while eating among obese people, and which genes influence weight loss in response to the obesity medication, sibutramine, in order to select the right patients for treatment of obesity with this medication. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Obesity is associated with medical and psychiatric co-morbidity and significant personal and societal costs. Obesity results from an imbalance of the intake and expenditure of energy. One of the crucial factors that determines energy intake is satiation or the feeling of fullness during and after food ingestion. Most attention has focused on centrally-mediated regulation of satiation. Our studies strongly suggest that gastric sensorimotor functions are significant determinants of postprandial symptoms and satiation. Thus, (i) Overweight and obese people ate more (average 225 kcal) prior to satiation. Increased fasting gastric volumes were associated with delayed satiation; (ii) the relationship between fasting volumes and satiation was confirmed in dyspepsia; (Delgado-Aros 2004a,2004b,2005) and (iii) in the previous cycle of DK67071, obese and overweight subjects had accelerated emptying of liquid nutrients and lower postprandial reduction in plasma levels of the orexigen, ghrelin; moreover, postprandial change in gastric volume was an independent predictor of satiation (Vazquez Roque 2006). Therefore, satiation may be mediated, at least in part, by alterations in gastric functions such as gastric emptying, fasting and particularly accommodation gastric volumes. In this cycle, our overall objective is to better understand the genes regulating gastrointestinal sensorimotor functions and satiety, and that significantly modify weight response to sibutramine and thereby identify candidates for prevention and treatment of obesity. Our interest in the relationship between genes and obesity was prompted by exciting observations from the prior cycle of DK 67071 that genetic variations that affect adrenergic receptor (ADR2A), G-protein β3 subunit (GNB3), and serotonin reuptake (5-HTTLPR) had a statistically and clinically significant impact on weight loss in response to sibutramine. These genotypes explained part of the variance in response to therapy, suggesting that other genes may explain residual variance. There are at least 17 loci that are associated with variation of BMI (Hofker 2009) and at least 18 common SNPs in type II diabetes mellitus (Zeggini 2008). The fat mass and obesity-associated gene, FTO, appears to be a "specific" obesity gene. The strongest association signal for childhood and adult onset obesity is with SNP rs1421085 in the first intron of FTO [p=10-12 (Meyre 2009)]. The FTO gene is also associated with satiety (Wardle et al. 2008, 2009). The gene most strongly associated with diabetes mellitus is the transcription factor 7-like 2 (TCF7L2) gene, which explains 17-28% of the population attributable risk (PAR) for type II diabetes mellitus in three Caucasian populations. A variant of the same gene, HapA, is positively selected in East Asian, European and West African populations and is associated with BMI and altered concentrations of the satiety hormones, ghrelin and leptin in males (Helgason 2007). It is conceivable, but presently unknown, that the effects of FTO and TCF7L2 on BMI are influenced through changes in satiation or gastric functions. Our preliminary data suggest, for the first time, that SNPs at FTO and other genes which have been linked to obesity and/or regulate appetite, also affect satiation or gastric functions. These genes affect adrenergic receptors (ADR2A, ADR2C, ADRB3), G proteins (GNB3), serotonin reuptake (5-HTTLPR) and uncoupling proteins (UCP) 2 and 3. In addition to association with obesity, these gene variants may influence response to therapy. Pharmacological agents can alter gastric emptying or volumes, and provide ways to alter satiation. Identifying susceptibility genes altering satiation and gastric functions may lead to personalized medicine. Hypotheses 1. Genes that are associated with obesity in epidemiological studies (FTO, ADRB3, and UCP-2) and with gastric functions (ADR2A, GNB3, 5-HTTLPR) are significantly associated with decreased satiation and disorders of gastric emptying, gastric volume or accommodation in overweight and obese adults. 2. TCF7L2, which is a gene predisposing to type II diabetes mellitus and satiety, is significantly associated with decreased satiation and disorders of gastric emptying, gastric volume or accommodation in obese or non- obese adults who are either normoglycemic or have impaired fasting glucose but not overt diabetes mellitus. 3. Markers of the genes that control ADR2A, ADRB3, GNB3, SLC6A4, FTO,TCF7L2 and UCP-2 and -3 cause differences in weight loss responses to sibutramine 15mg per day for 12 weeks. Aims 1. To compare maximum tolerated volume, postprandial satiation, gastric emptying, fasting and postprandial accommodation volume in adults with gene variants of FTO, ADRB3, UCP-2, ADR2A, and GNB3 with results in adults with wildtype genes. 2. To compare maximum tolerated volume, postprandial satiation, gastric emptying, fasting and postprandial accommodation volume in obese and non-obese, non-diabetic adults, and in adults with impaired fasting glucose who are carriers of the diabetes-associated TCF7L2 allele vs. adults with the diabetes-protective allele. 3. To assess the pharmacogenetic modulation of weight loss in response to sibutramine 15 mg per day compared to placebo for 12 weeks in obese and overweight adults with allelic variation in ADR2A, GNB3, SLC6A4, FTO, TCF7L2 and UCP-2 compared to adults with common or disease-protecting allele.